Inference of heterogeneous transmission of antimicrobial resistant pathogens in health care settings

PROJECT SUMMARY/ABSTRACT
Antimicrobial resistance (AMR) was associated with over 4.95 million deaths globally in 2019 and is projected
to cause over 10 million deaths annually by 2050. Healthcare systems are the critical settings where novel
AMR organisms (AMROs) may emerge and spread to the broader community. Strategies for cost-effective
AMRO containment in healthcare settings should target locations and individuals that contribute most to AMRO
transmission; however, effective inference methods to accurately identify these targets are currently lacking.
The objective of this project is to develop novel inference systems to quantify heterogeneous transmission
rates in hospital wards and identify individuals carrying AMROs for six high-priority organisms in four major
hospitals in New York City. We will use electronic health records, hospitalization information, laboratory test
results, and genetic sequence data to pursue two specific aims: 1) infer location-specific transmission rates for
multiple AMROs in hospital wards; 2) estimate individual-level AMRO carriage probabilities using multi-type
observations. The project will leverage an innovative combination of advanced modeling techniques, new
inference methodology, and unique datasets on multiple co-circulating AMROs. The specific aims build on our
prior research on modeling and inference of AMROs and abundant preliminary analyses. The proposed
research is significant because it addresses a pressing need in global public health – the emergence and
spread of AMR pathogens in healthcare settings. The expected outcome of this project will produce novel
inference methods for identifying hospital wards and individuals driving the spread of multiple AMROs in
healthcare systems. As the data sources used in the studies are widely available in electronic health records,
the inference system can be generalized for use in other hospital systems.

Public health relevance
PROJECT NARRATIVE Cost-effective control of antimicrobial resistance (AMR), an urgent global public health threat, needs to target locations and individuals that drive the transmission of AMR organisms in healthcare settings. This project will develop a series of novel inference methods to quantify heterogeneous transmission rates in hospital wards and identify individuals carrying AMR pathogens for six high-priority organisms in four major hospitals in New York City. The proposed studies will produce inference frameworks synthesizing multi-type observations that are readily available in electronic health records to inform improved interventions, which can be generalized to other healthcare facilities.